Development of Blister packs for intradermal delivery of high-viscosity suspensions

Project summary
Injectable drugs constitute a $400+ billion market worldwide, and the range of devices for delivery
is expanding to improve factors such as patient compliance, reduced pain, self-administration,
and delivery efficiency. Intradermal delivery is especially pertinent in this regard for potential
confluences of reduced pain, fast immune response and fractional dose vaccination. Also high on
the priority list for delivery technologies are nucleic acids, which are seen as promising biological
drugs for a range of immune disorders and infectious diseases. There are currently over 900
biological drugs on the market or in development. Amongst these, plasmid DNA vaccines have
been widely studied over the last two decades and are being developed for Ebola, MERS, Zika,
Hepatitis B, and HIV. However, a major obstacle is the method of delivery due to the large physical
size of the molecules, which can render products that are high-viscosity, creating issues for
injectability with standard hypodermic needles.
This exploratory grant will develop prototype devices, based on blister-pack concepts, for
intradermal injection of viscous suspensions, with the primary target being DNA products. Guided
by approaches using hollow microneedles, we will fabricate and test single-orifice and multi-orifice
modules that target intradermal delivery. The prototypes will be tested across a broad range of
fluid viscosities and existing drugs. The proposed study comprises a proof-of-concept for our
devices using ex-vivo tissues, and limited in-vivo studies using guinea pigs, a clinically relevant
model for intradermal delivery. The overarching goal is to optimize intradermal delivery,
specifically with regards to high-viscosity products in order to advance the feasibility of
widespread DNA vaccination.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will develop a novel technology that can deliver a range of injectable drugs across the skin. The proposed devices will be easy-to-use, low-cost, and scalable, so they are suited for use in developing countries. The project is also perfectly aligned with current NIH goals to increase the range of platform technologies for delivery of nucleic acids.